2024 Annual Meeting of the American Society for Investigative Pathology

The 2024 Annual Meeting of the American Society for Investigative Pathology (ASIP) will be held April 20-23 at
Renaissance Baltimore Harborplace Hotel in Baltimore, MD. The Annual Meeting of the ASIP provides a unique
forum for presentation and sharing of cutting-edge research in experimental pathology. The target audience and
subject matter for the meeting are diverse, but united by a common focus on mechanisms of disease. Reflecting
the interests of the ASIP membership, the four-day scientific program for the 2024 Annual Meeting is comprised
of major symposia, award lectures, workshops, guest society symposia, and special sessions covering disease
pathogenesis, biomarker development, prevention, diagnosis, and therapeutics, advanced technologies, organ
systems, and systems biology. This program contains strong components in cancer pathobiology. Major cancer-
related sessions will focus on: (i) Cancer and Obesity; (ii) Spatial Transcriptomics in Human Specimens; (iii)
Cutting Edge Technologies for the Future of Breast Cancer Prevention, Detection, and Screening; (iv)
Metabolism and Cell-cell Crosstalk in Chronic Liver Disease and Liver Cancer; and (v) Artificial Intelligence in
Biomedical Research. In addition, the ASIP Outstanding Investigator Award Lecture will have a specific cancer-
focus: Oxygen Sensing Signaling in Cancer: The Past, Present, and Future. Additional opportunities for
presentation of cancer-focused research will include abstract-driven minisymposia and poster discussion
sessions, which will intentionally feature young investigators and trainee scientists. The program further provides
a number of sessions focused on education and career development. These sessions are designed for trainees
and young investigators, but are open to all attendees. Education and career development topics for 2024
include: (a) Recognizing Racism in Graduate/Medical Curriculum, (b) Building a Positive and Productive
Research Laboratory Culture, and (c) Practical Applications in Artificial Intelligence. In addition, the Women in
Pathology will hold a special session on Powerful Questions for Connecting, Collaborating, and Building
Confidence. The ASIP regards promotion of the career development of trainee and young investigators as an
extremely important aspect of the Annual Meeting. Accordingly, the meeting provides not only special events
designed for their needs, but also sessions that highlight/showcase their work. Similarly, the Program Committee
works hard to ensure diversity among the participants with respect to gender, ethnic/racial group, stage of career,
and institutional affiliation. For 2024, among invited speakers: 42% are women, 55% are Assistant/Associate
Professors (or equivalent), and 90% of major sessions include speakers that are women or underrepresented.
The sole specific aim of this application is to promote the participation of trainees and young investigators in the
2024 Annual Meeting through provision of a Scholar Award program targeted to graduate students, postdoctoral
fellows, clinical residents/fellows, and junior faculty members.

Public health relevance
The Annual Meeting of the American Society for Investigative Pathology offers a unique forum for the sharing of original research results related to a wide spectrum of human diseases and disorders, with particular emphasis on the development, treatment, and prevention of cancer. Such sharing fosters more rapid advances in the understanding of human diseases such as cancer and accelerates the rate at which this knowledge can be applied to the development of diagnostic and prognostic tests, as well as targeted therapies. A major goal of the meeting is to provide educational and career support to trainees and other young investigators who are interested in cancer biology and experimental pathobiology.